The role and mechanism of RNA m6A modification in the pathogenesis and drug-resistance of prostate cancer

PROJECT TITLE:
The role and mechanism of RNA m6A modification in the pathogenesis and drug-resistance of prostate cancer
PROJECT SUMMARY (ABSTRACT):
Background: N6-methyladenosine (m6A) modification is the most prevalent and abundant internal modification in
eukaryotic messenger RNAs (mRNAs) and plays diverse and important roles in normal biological processes.
Emerging evidence suggest that m6A and m6A-assicated proteins also play critical roles in human diseases
including cancers. Prostate cancer (PCa) is the most commonly diagnosed cancer with the second leading
estimated deaths at the United States for more than a decade. Androgens and androgen receptor (AR) regulate
normal growth and function of the prostate gland. However, aberrant regulation of androgens and AR signaling
pathway are closely associated with PCa pathogenesis and progression. Thus, androgen deprivation therapies
(ADT) or targeting AR function have always been the mainstay of therapeutic strategy against advanced prostate
cancers. However, the current therapeutic strategies cannot cure most PCa patients due to drug resistance and
relapse, and eventually develop metastatic, castration-resistant prostate cancer (mCRPC), a lethal stage of the
disease. The acquired resistance to abiraterone and enzalutamide is considered as the main problem for the
treatment failure and relapse of PCa. Therefore, it is crucial to elucidate the molecular mechanisms underlying
PCa pathogenesis and drug resistance, which may contribute to the development of effective new therapeutic
approaches to overcome the limitations of current treatment for PCa. RNA m6A modification is deposited by m6A
methyltransferase complex composed of three core subunits METTL3, METTL14 and WTAP and may have
functions as an important regulator of gene expression that can affect mRNA transcription, splicing, export,
stability, and translation. Previously, we have reported that METTL3-catalyzed m6A modification of target mRNA
plays critical oncogenic roles in human cancers including PCa, but its definitive roles in AR signaling activation
and especially in drug-resistant AR signaling remain elusive. Our preliminary data imply that m6A modification
on enhancer RNAs (eRNAs), which are regulatory RNAs transcribed from non-coding enhancer elements, may
also have roles in drug resistance in PCa, which requires further systematic studies. The goal of this proposal is
to prove the central hypothesis that METTL3-mediated RNA m6A modification plays essential roles in AR
signaling, PCa pathogenesis and drug resistance. The m6A methylome of chromatin-associated regulator
RNAs (carRNAs) and nascent RNAs will be mapped, analyzed and correlated with the genome-wide binding of
AR and transcriptional machineries. Also, the role of YTHDC1, a nuclear m6A reader protein, will be systemically
examined to investigate its relationship with the transactivation of AR and genome-wide distribution, as it has
been known to regulate transcriptional activation or repression via binding to m6A-modified RNAs. Loss- and
gain-of-function experiments will address the widespread impact of RNA m6A modification in controlling the
activation of AR signaling and downstream gene expression, and thus will help uncover the molecular
mechanism underlying the role of m6A modification in PCa pathogenesis. Finally, the effects of m6A modification
manipulation in the AR signaling regulation with drug-resistant AR mutations will be explored using a xenograft
PCa mouse model, as well as a patient-derived xenograft (PDX) models and a panel of assays will be placed to
examine the underlying molecular mechanism. Our proposed study will successfully reveal the role of RNA m6A
modification in AR signaling and PCa pathogenesis, and help evaluate the clinical potential pharmacological
inhibition of m6A modification in PCa, especially metastatic and drug resistant PCa.

Public health relevance
PROJECT NARRATIVE The persistent activation of the androgen receptor signaling pathway has been observed in primary prostate cancer (PCa) as well as aggressive prostate cancer including castration-resistant prostate cancer (CRPC) or drug-resistant prostate cancer. Methylation of adenosine at nitrogen-6 position (m6A) on RNA molecules have been implicated to the pathogenesis of PCa through abnormal alteration of m6A levels deposited by METTL3, which is m6A methyltransferase. Our proposed studies aim to understand how the m6A modification and nuclear m6A reader YTHFC1 mediate the transcriptional activation of androgen receptor (AR), which is critical to the pathogenesis of PCa, and how the persistent activation of AR signaling in castration- or drug-resistant prostate cancer is associated with biomolecular condensation. This study will evaluate and propose the clinical potential of pharmacological inhibition on m6A deposition in the PCa pathogenesis-associated transcriptional regulation through AR.